Positronium lifetime imaging using TOF PET

Project Summary/Abstract
Positron emission tomography (PET) is a high-sensitivity molecular imaging modality widely used in oncology,
neurology, and cardiology, with the ability to observe molecular-level activities inside a living body through the
injection of specific radioactive tracers with positron emitters. Recently it has been shown that the lifetime of
positronium, a metastable state formed by a pair of electron and positron, is sensitive to the microenvironment
of the surrounding tissue, such as oxygen pressure. Such information is valuable for cancer staging and
treatment planning. However, currently there is no practical method to imaging the positronium lifetime at a
spatial resolution matching that of PET due to the limited photon detection sensitivity and lack of proper image
reconstruction method. This proposal addresses these problems by developing a statistically based image
reconstruction method for positronium lifetime imaging (PLI) and combining it with the newly developed total-
body EXPLORER PET scanner at UC Davis. We will demonstrate the effectiveness of the method using
phantom experiments on the EXPLORER scanner. The advantage of the PLI is that the lifetime measurement
is independent of the tracer concentration and can be used together with standard PET imaging. The
combination of PLI and PET will add another dimension to current PET imaging and provide useful information
for understanding the microenvironment of the tissue for studying various human diseases.

Public health relevance
Project Narrative Positron emission tomography (PET) is a medical imaging technique widely used in clinic for detecting cancer, cardiovascular diseases, and neurological disorders. This project will develop a new positronium lifetime imaging technique using existing PET scanners to provide information of the tissue microenvironment for studying human diseases.